Preclinical/Co-Clinical Section

PROJECT SUMMARY PRECLINICAL/CO-CLINICAL CORE
The Jackson Laboratory (JAX) and The Jackson Laboratory Center for Precision Genetics (JCPG) occupy a
unique niche within the global biomedical research community. Although we do not see patients, many of
these individuals have benefited from our stewardship of the thousands of different mouse strains that JAX
provides for use in human disease research. And it is not just our mice; our faculty researchers, with deep
expertise in genetics and mammalian biology, collaborate directly with investigators at hospitals, medical
centers and an array of other clinically oriented partners worldwide. Thus, the JCPG will operate using a “hub
and spokes” concept where the JCPG forms part of a mammalian disease model “hub” that integrates a variety
of JAX resources to establish an array of collaborative “spokes” with a variety of partners to co-produce precise
preclinical disease models. The Preclinical/Co-clinical core of the JCPG will work with expert clinical, patient,
research and industry collaborators to facilitate optimal creation and application of existing and nominated
projects. Together with the JCPG Coordination Core, the Preclinical/Co-clinical Core and the Steering
Committee will apply a series of benchmark standards to work toward the eventual goal of translation into
clinical practice. Ultimately, we will further extend our impact by providing a more advanced Fee for Service
approach to broaden community access to JAX resources. To meet current goals of the JCPG and to refine
and expand its future operation, the Preclinical/Co-clinical Core will: 1) Solicit, evaluate and prioritize new
preclinical/co-clinical project requests and provide recommendations to the Steering Committee for adoption by
the JCPG. 2) Advance new models through the production-like pipelines, with characterization and drug
testing so they can more tangibly inform future clinical applications. 3) Continue to develop and expand
existing JAX infrastructure to facilitate access to clinical data and samples, supporting data exchange between
mouse information and patient data.